Cancer Research Training and Education Coordination

PROJECT SUMMARY/ABSTRACT
The Markey Cancer Center (MCC) at the University of Kentucky collectively delivers highly successful
training programs spanning from K-12 to faculty level through the Cancer Research Training and Education
Coordination (CRTEC) component. MCC’s CRTEC programs and activities are structured around specific aims
to: 1) Generate early interest in cancer-related careers, emphasizing those underrepresented in science; 2)
Promote education and career development of a diverse cadre of graduate and postdoctoral cancer
researchers; and 3) Foster research faculty career development in basic, population and clinical/translational
sciences. Key education activities address the academic challenges across medically and educationally
underserved rural Appalachian Kentucky and for underrepresented minorities through support from five grants
that include an NCI Youth Enjoy Science R25 program. These efforts complement impactful structured
academic and research training at the graduate, postdoctoral and medical residency levels, including three
NCI-funded T32 training grants. Through new initiatives such as the recently funded NCI T32 focused on
health equities and undergraduate research programs targeting underrepresented and underserved
populations, MCC’s CRTEC component expands its comprehensive training reach to implement bold diversity
initiatives that complement well-established and emerging state-of-the-art cancer curricula and enrich MCC
Research Programs. The establishment of sustainable NIH-funded Centers of Biomedical Research
Excellence awards with dedicated cancer themes and associated junior faculty mentorship augment MCC’s
long-standing American Cancer Society Institutional Research Grant support for early-stage faculty and
effective team-based faculty mentorship mechanisms across basic, population and clinical research levels that
are significantly expanding MCC’s extramural funding base. Further targeted mentorship of early career clinical
investigators through mechanisms such as the Clinical Trials Boot Camp fosters the development of
investigator-initiated trials that translate MCC science to the clinic. The MCC Affiliate Network provides an
effective conduit for multi-faceted statewide training of health care professionals in state-of-the-art cancer care,
which is needed to address the tremendous cancer burden within Kentucky and the region. A rich cadre of
seminars, symposia, meetings and career enrichment activities facilitate successful career development for all
individuals engaged in cancer research and clinical practice. The MCC’s collective efforts draw on vital
institutional training resources to achieve the overarching goals of this program, which are to guide cohesive
growth and coordinate transdisciplinary education and mentoring endeavors across the MCC and integrate
them with efforts campus-wide and nationally. Through coordination supported by MCC’s Cancer Center
Support Grant, this comprehensive program will continue to evolve innovative curricula and strategically linked
initiatives to prepare trainees and faculty for evolving cancer career opportunities.

Public health relevance
Project Narrative Not applicable. This document is attached to satisfy electronic submission requirements.